Glioma Circuitry: Bridging Systems Neuroscience and Cancer

Project Summary
High-grade gliomas, such as glioblastoma and diffuse intrinsic pontine glioma (DIPG), represent the leading
cause of brain cancer-related death for both adults and children. Among the most intractable human cancers,
these tumors are quick to recur and nearly impossible to eliminate. A fundamental shift in our approach to
glioma therapy is in dire need. My research group has recently discovered that gliomas grow in response to
nervous system activity and further that gliomas exhibit a surprisingly profound dependency on these neuronal
mechanisms. Our cellular and molecular work has led us to the startling realization that gliomas functionally
integrate into electrically active neuronal circuits through bona fide neuron to glioma synapses, and the effects
of neuron to glioma signaling may be amplified throughout the tumor via a network of recently described
glioma to glioma gap junction-mediated connections. We hypothesize that this cooperative, interconnected
network of glioma cells and neurons is fundamental to high-grade glioma progression and therapy resistance.
Effective therapy for this lethal group of brain cancers may therefore require targeting not only molecular
mechanisms of cell proliferation and survival, but also patterns of membrane depolarization and structural
connections between cells. In order to study this, a shift from the predominant cellular/molecular perspective
of cancer biology to a systems neuroscience approach is required. In the present proposal, we seek to apply the
powerful next-generation tools of modern systems neuroscience together with patient-derived orthotopic
xenograft models of high-grade gliomas to map, monitor and control the circuit dynamics of high-grade
gliomas at progressive time points during the course of the disease. Optogenetic control of neuronal action
potentials and of glioma membrane depolarizations together with live calcium imaging in awake, behaving
mice will elucidate the functional significance of various temporal and spatial patterns of glioma circuit activity
to glioma growth. Molecular interventions aimed at disassembling the various components of the neuronal-
glioma network will discern the relative contribution of each and identify novel therapeutic targets. Ultimately,
therapeutically modulating malignant circuit activity may prove transformative for high-grade glioma
outcomes.!

Public health relevance
Project Narrative High-grade gliomas are intractable cancers representing the leading cause of brain tumor-related death in both adults and children. The activity of neurons in the tumor microenvironment robustly regulates high-grade glioma growth, and we have recently discovered that a subset of high-grade glioma cells integrate into neural circuitry through electrophysiologically functional excitatory synapses between glutamatergic neurons and high-grade glioma cells. A potentially transformative hypothesis we now seek to test posits that high-grade gliomas form an interconnected, cooperative network between neurons and the cancer cells invading the brain through which waves of membrane depolarization and subsequent calcium fluxes propagate, and that particular patterns of glioma circuit activity sustain and support cancer growth; disrupting or “pacing” glioma circuit activity may therefore prove a crucial therapeutic intervention.